2019-2021 Annual Meetings of the Environmental Mutagenesis and Genomics Society (EMGS)

The Environmental Mutagenesis and Genomics Society (EMGS) is the primary scientific society fostering
research on basic mechanisms of DNA repair, mutagenesis, and environmental epigenetics and application of
this knowledge to understanding human health effects from environmental exposures. Studies of DNA repair,
mutagenesis, and epigenetics by EMGS scientists are integrated with research on inherited and acquired
genetic alterations that predispose individuals to cancer, premature aging, neurodegenerations and birth
defects. Fundamental understanding of the mechanisms and consequences of cellular, tissue, whole
organism, and human population responses to genotoxic agents is crucial to informed regulatory decision-
making with respect to environmental health hazards. The integration of multi-disciplinary basic and applied
research is essential to this process. Such integration remains the central focus of the EMGS, and the annual
meetings are key to the dissemination of information and fostering the necessary interactions. In addition,
meetings provide an important forum for students and new/early stage investigators to present their research
and to interact with leading scientists in their field in a setting that encourages open exchange of ideas. The
50th Annual Meeting of the EMGS will be held in Washington D.C. from September 19-23, 2019. The theme is
“Environmental Mutagenesis and Genomics: The Next Fifty Years”, encompassing areas of current research
that converge on the issues of environmental exposure, how cells and organisms respond to such challenges,
and how this information can be applied to promote human health in the era of high-throughput data. The
themes for the 51st and 52nd Annual Meetings will be selected approximately a year before each meeting.
Comprised of symposia, workshops, plenary lectures, platform and poster sessions, the Annual Meeting will
encompass the full range of scientific interests within the Society, bringing together academic, industrial, and
governmental scientists interested in how environmental factors lead to genotoxic and epigenetic outcomes.
The objectives of this application are to request funds for Travel Awards for students and new/early stage
investigators to attend the Annual Meeting and partial support for travel expenses of invited speakers. Travel
Awards assist in offsetting the financial burden that might otherwise prevent students and new/early stage
investigators from attending. Support to defray travel costs for invited speakers enables the Society to provide
the greatest value at lower costs to attendees. Speakers from both within and outside the society provides the
cross-fertilization of research and ideas necessary for a world-class meeting.

Public health relevance
Members of the Environmental Mutagenesis and Genomics Society (EMGS) have expertise in multiple disciplines covering all aspects of basic and applied research on mechanisms and consequences of responses to genotoxic agents. Integration of these disciplines remains the central focus of the Society, and the annual meetings are key to the dissemination of information and fostering of interactions between researchers and individuals who must make informed regulatory decisions with respect to environmental health hazards. The meetings provide a forum in which students, postdoctoral fellows, and early stage investigators can develop and enhance their careers by sharing information with established scientists through formal scientific sessions and informal interactions.